Obesity in ciliopathies: How neuronal primary cilia control appetite

Project Summary/Abstract
We investigate how neuronal primary cilia regulate energy homeostasis and how
their dysregulation causes obesity. Primary cilia are cell surface projections that receive
and transduce select intercellular signals. In humans, disruption of primary cilia function
causes ciliopathies, pleiotropic diseases of which obesity is a cardinal manifestation. The
most common monogenic cause of severe human obesity is mutation of MC4R, encoding
a hypothalamic GPCR that regulates energy homeostasis.
In the initial funding period of this project, we have demonstrated that MC4R
localizes and functions at the primary cilia in vivo, and that its localization and function are
dependent on the MC4R-associated protein MRAP2. We also found that inhibiting
adenylyl cyclase in the primary cilia of MC4R neurons causes obesity. These findings
suggest that hypothalamic neurons use cilia to communicate through MC4R to regulate
energy homeostasis.
Here, we build on these findings, and on new genetic and molecular tools we have
developed, to investigate how ciliopathies disrupt ciliary MC4R signaling, how the ligands
of MC4R regulate its localization to cilia, and how MC4R activity is transduced by the
cilium. Together, these experiments will illuminate how cilia signaling encodes long-term
energy homeostasis and how neurons use cilia to communicate non-synaptically.

Public health relevance
Project Narrative Obesity is a major public health concern, as it increases the risk for diabetes, heart disease and certain forms of cancer. Obesity, particularly in its most severe form, has an extremely strong genetic basis. Unfortunately, most of the genes that predispose people to obesity, as well as the molecular and cellular pathways those genes participate in, remain unknown. This project builds on the expertise and established collaborative work of two investigators to illuminate how dysfunction of neuronal primary cilium, a specific sub-cellular compartment that functions as an intercellular antenna, causes obesity.